EXELON IN MILD TO SEVERE PROBABLE ALZHEIMER'S DISEASE IN COMMUNITY SETTING

Eighty week study to evaluate safety and efficacy of Exelon in open- label format for mild to severe Alzheimer's Disease. The medication is a cholinesterase inhibitor.